Emerging Mechanisms of Replication-coupled DNA Repair

Cells are constantly exposed to exogenous and endogenous agents that chemically damage the genome. During
DNA replication, this chemical DNA damage can introduce mutations, chromosomal rearrangements, and
chromosome mis-segregation events that contribute to progression of cancer and ageing. DNA interstrand cross-
links (ICLs) are highly toxic DNA lesions that covalently link the two strands of DNA and block unwinding by the
replicative CDC45/MCM2-7/GINS (CMG) helicase. These lesions are generated by cancer chemotherapeutics,
endogenous metabolites, and microbiome toxins. Deficits in ICL repair cause the bone marrow failure and cancer
predisposition syndrome Fanconi anemia (FA). The products of genes implicated in FA participate in a common
ICL repair pathway that is activated when CMG collides with an ICL. Replication fork stalling at the ICL initiates
nucleolytic incisions that convert the ICL into a DNA double strand break (DSB). The DSB is itself a potential
source of genome instability that must be repaired by homologous recombination. In previous work, we used
Xenopus egg extracts to demonstrate that certain ICLs are repaired by an alternative pathway that is also
activated upon CMG collision with an ICL. In this pathway, the NEIL3 glycosylase cleaves an N-glycosyl bond in
the cross-link, resolving the ICL without DSB formation but generating a labile abasic (AP) site. Our work
indicated that the NEIL3 pathway is the preferred response for resolving a subset of ICLs, though the FA pathway
can process these lesions when NEIL3 is inactivated. We further showed that the AP site produced by NEIL3
forms a DNA-protein cross-link with the HMCES protein, which stabilizes the AP site and regulates mutagenic
DNA synthesis past the AP site. These results indicate that multiple functionally distinct pathways can cooperate
to promote efficient replication-coupled repair of DNA damage. In this proposal we will use approaches spanning
biochemistry, molecular biology, and cell biology to investigate how repair mechanisms are coordinated at the
replication fork during repair of physiologically- and clinically-relevant DNA lesions. In Aim 1, we will determine
the mechanisms of repair for an ICL formed by a bacteria toxin implicated in cancer progression, providing new
insight as to how the chemical structure of an ICL influences repair. In Aim 2, we will explore the repair of ICLs
by the NEIL3/HMCES pathway, including examining how this pathway is activated and how it regulates ICL
repair outcomes. In Aim 3, we will examine how HMCES regulates AP site metabolism and contributes to
genome stability in cells. These experiments will provide a deeper understanding of how different biochemical
repair activities are integrated at stalled replication forks. This work has the potential to inform therapeutic
interventions that modulate replication-coupled repair to sensitize cancer cells to chemotherapy or halt
progression of diseases caused by DNA repair deficiencies.

Public health relevance
Chemical damage to DNA is a major source of replication stress that can induce genome instability and drive the progression of cancer and ageing. This proposal investigates the mechanisms that enable the cellular DNA replication machinery to tolerate and repair DNA damage. Insights generated by this work may therefore inform the development of interventions that modulate replication stress to treat cancer and genetic diseases.